NUTRITIONAL STATUS, PHYSICAL GROWTH, AND NEURODEVELOPMENT IN INTERNATIONAL ADOPT

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The overall goal of this proposed project is to develop a comprehensive nutritional battery for the IA population and to assess the role of changes in nutritional status on neurobehavioral development.